A multimodal examination of functional network health and its relationship with tau deposition

Abstract
Alzheimer’s disease (AD) affects millions of people worldwide, and its prevalence is expected to increase
dramatically in the coming years. Although some people are resilient to AD pathology with normal cognition
despite tau and amyloid deposits, understanding the factors that drive such resilience will be critical for identifying
treatments for those at the highest risk of impairment. In the research proposed here, we will use cognitive
neuroscience methods to develop a systems-level understanding of the mechanisms that underlie early-stage
AD. We will examine tau deposition and functional network health in a sample of participants with normal
cognition to understand the etiology of AD and individual differences in cognitive resilience. Recent results have
shown that tau is present in different parts of the brain in different people. Thus, we hypothesize that tau deposits
in a particular brain network disrupt functional network health, and patients who appear cognitively normal
despite pathology have tau deposits in locations that have a minimal impact on functional networks.
To test this hypothesis, we will use tau positron emission tomography (PET) to quantify the spatial distribution of
tau pathology. We will also determine the role of brain network connectivity and atrophy in the health of a cohort
of diverse participants enriched for individuals at risk for AD. In Aim 1, we will use data from the publicly available
Alzheimer's Disease Neuroimaging Initiative dataset to test our hypotheses by determining how tau deposits
affect the health of pre-defined brain networks. We will measure functional network health based on network
segregation, neural dynamics, and cortical atrophy. In Aim 2, we will determine how segregation, dynamics,
atrophy, and tau deposits affect network flexibility. We will recruit 150 cognitively normal participants aged 55 or
older from diverse populations enriched in participants with blood markers indicating tau and, thus, at high risk
for developing AD. They will undergo tau PET and resting-state functional magnetic resonance imaging (fMRI)
as part of a University of Alabama at Birmingham Alzheimer's Disease Center study and will undergo fMRI during
an auditory/visual attention task. In Aim 3, we will determine how these variables interact to affect cognitive and
sensory performance and whether they predict longitudinal cognitive decline. Successful completion of this work
will result in a better understanding of how tau deposits affect the normal patterns of brain activity and patterns
of brain atrophy. These studies will provide new information on the mechanisms through which tau results in a
system-wide decline and the conditions that lead to resilience. This knowledge may suggest treatments for
patients with AD and patient-specific training or behavior modification strategies that, applied early in the course
of AD, could mitigate its long-term effects.

Public health relevance
Narrative Tau tangles in Alzheimer's disease are associated with cognitive impairment, but some patients are resilient to this pathology. We aim to understand why and how tau pathology affects brain networks, which is crucial for developing effective treatments for high-risk patients. Using tau positron emission tomography and functional magnetic resonance imaging, we will determine the relationship between network architecture and cognitive decline in a diverse sample of participants at risk for Alzheimer's disease.